Improving the Telehealth Delivery of Care for Older Veterans with Cancer and Cognitive Impairment

Alzheimer’s disease and related dementias (ADRD) and cancer impose a heavy burden on patients and their
caregivers and are major contributors to US healthcare expenditures. Given the rapidly growing aging
population at risk for both conditions, there is a critical need to understand how to improve care for those with
comorbid cancer and cognitive impairment. Patients with dual diagnoses of cancer and cognitive impairment
including ADRD have worse outcomes and unique care needs that require more person-centered care. The
unique care needs of patients with comorbid cancer and cognitive impairment cannot be met with current
oncology clinic workflow and staffing and time constraints. Oncology care must address the unique care needs
of these patients through multi-dimensional interventions for the clinic environment, providers, patients, and
caregivers that can be customized to different degrees of cognitive dysfunction and available supports.
Increased telehealth use within VA hospitals has helped relieve some of the burdens on patients and
caregivers, and telehealth oncology care is expected to be an integral, growing part of VA oncology care in the
foreseeable future. However, there is limited evidence and guidance on telehealth use for complex patients like
those with cancer and cognitive impairment including ADRD. In fact, the rapid telehealth expansion may
unintentionally exacerbate the already complex care needs of high-need Veterans. There is a critical need to
proactively design care processes to address the needs of these vulnerable patients. The goal of this project is
to improve the telehealth delivery of cancer care for older, cognitively impaired Veterans on active cancer
treatment by 1) understanding the telehealth oncology experiences of patients with cognitive impairment, their
caregivers, and clinicians, and 2) developing and testing a multi-dimensional intervention that can be
customized to different degrees of cognitive dysfunction and available supports. Eligible participants are
clinicians providing telehealth oncology care and patients who meet the following inclusion criteria: age 65 or
older, on active cancer treatment, has received any part of their care through telehealth (phone or video),
Montreal Cognitive Assessment (MoCA) score <26, able to speak English and provide consent. We will start
with a convergent parallel mixed-methods study to interview and survey clinicians, older Veterans with cancer
and cognitive impairment undergoing active treatment via telehealth, and their caregivers (Aims 1-2). We will
use these data to develop an intervention guided by principles of the Consolidated Framework for
Implementation Research and Capability-Opportunity-Motivation model of Behavior change (Aims 1-2). We will
then pilot test this multi-dimensional intervention using adaptive design principles (Aim 3). Cognitive
impairment will be stratified by milder (MoCA 18<26) versus more severe cognitive impairment (MoCA <18) as
care needs are expected to vary by severity of cognitive impairment. The primary endpoint is acceptability as
assessed by System Usability Scale score ≥70, and the secondary endpoint is feasibility as assessed by
recruitment rate ≥70%. We will also examine potential targetable outcomes such as subjective cognitive
function, functional status, distress, treatment adherence, and caregiver burden. The proposed research is
significant because it addresses a critical unmet need and helps advance scientific knowledge in how to
improve care delivery for patients with two of the most common and morbid age-related diseases—cancer and
ADRD. This project will be a high impact way to improve care for Veterans that is aligned with multiple VA
Health Services Research and Development priorities. This work has many potential future applications,
including conducting a larger efficacy trial to test the telehealth-focused intervention across other VA sites,
expanding the intervention to include in-person oncology care, or adapting our telehealth-focused intervention
for other complex chronic diseases that are often comorbid with ADRD.

Public health relevance
Cancer and cognitive problems including Alzheimer’s disease are common diseases of aging that often occur together and impose heavy burdens on patients and caregivers. Cancer patients with cognitive problems have worse health outcomes and need personalized cancer care that often cannot be met by current oncology clinic workflows. Growing telehealth use within the VA has helped relieve some of the burdens on patients and caregivers, and telehealth is expected to be an integral part of future VA cancer care. However, there is limited guidance on its use for complex patients. There is a critical need for oncology clinics to proactively design care processes that can meet the unique needs of older cancer patients with cognitive problems. The goal of this project is to deeply understand the telehealth oncology experiences of patients, caregivers, and clinicians in order to design and test a patient-centered intervention to improve telehealth cancer care delivery, so telehealth cancer care can be equitable for all Veterans regardless of age and memory and thinking abilities.